CSHL 2025 Eukaryotic DNA Replication & Genome Maintenance Conference

This conference will be the 20th biennial meeting on Eukaryotic DNA Replication and Genome Maintenance and follows the highly successful meetings that have been held at Cold Spring Harbor (CSHL) every other year since September 1987. It is the only regularly occurring meeting that is exclusively focused on eukaryotic DNA replication. Because of this focus, the meeting has played a major role in accelerating our understanding of eukaryotic DNA replication and how it is integrated into the cell division cycle. This year’s conference will be devoted to fundamental research topics related to chromosome duplication, structure and function, and will include important research in the areas of cell cycle and growth control, chromatin and developmental influences on replication, and the response of the replication apparatus to DNA damage. As the field continues to move forward, we have placed an increased emphasis on the central role of DNA replication in the DNA damage and replication stress response, and strategies used by cells to minimize threats to genomic integrity arising from DNA replication. The ongoing convergence of the DNA replication and DNA damage response fields makes this a timely meeting. The format of the meeting will ensure that recent results are communicated and discussed face-to-face, which will enhance progress and collaboration. The participation of young investigators is promoted through the selection of chairs and speakers chosen from the abstracts.
The 2025 meeting will include an array of topics, systems, and approaches including studies of chromosomal replication and genome stability in organisms as diverse as yeast, plants, flies, frogs and mammals. Sessions will cover (1) Replisomes, replication progression, and termination; (2) Replication initiation; (3) Developmental control of replication; (4) Replication origins; (5) Genome instability, cancer and other disease; (6) Endogenous sources of replication stress; (7) Mechanism of replication stress response; and (8) Chromatin and replication timing. Uncontrolled DNA replication is a hallmark of tumors and errors in DNA replication lead to genomic instability, and the process of chromosome replication is a major target for chemotherapy, radiotherapy, and novel cancer therapeutics. The relevance of this meeting to cancer research, and ultimately to improved therapies, cannot be overemphasized.
Replication of DNA is a fundamental process in all (eukaryotic) life. This meeting will focus on understanding the mechanism by which this process occurs, and how DNA replication contributes to genome stability, maintenance of the epigenetic state of a cell and how mis-regulation of these processes contribute to diseases, most notably, cancer. The intellectual merits of this conference include the opportunity for leading investigators at all stages of their scientific careers to share and discuss their latest results and concepts. The informal peer review in oral and poster sessions is invaluable for providing rapid feedback that will fruitfully steer and accelerate future research. This conference also provides ample opportunity for learning and for building collaborations. We do not plan parallel sessions within the schedule so that all attendees share a common experience, while the secluded venue at CSHL maximizes the likelihood of productive scientific exchange.
Large, established conferences generally can have significant impact, and this CSHL meeting has undoubtedly driven forward research in DNA replication. Unique aspects of this conference that have particularly broad impact are the active participation of younger scientists, including as session leaders, who will particularly benefit from the opportunity to present their latest ideas. The conference archive (Leading strand video archive accessible by the internet) allows participants to share aspects of the conference with their colleagues who were unable to attend while protecting the right of authors to present unpublished research.

Public health relevance
For all unicellular and multicellular organisms, the entirety of their DNA (i.e. their “genomes”) must be duplicated with minimal errors every time a cell divides. In higher plants and animals, the genome is packaged together with specialized proteins into structures called chromosomes that are themselves organized within a cell’s nucleus. How the DNA within chromosomes is accurately replicated to allow duplicated copies of each chromosome to be passed on to the two daughter cells resulting from cell division is a central question in biology. This process involves multiple “proof-reading” and “error-correction” mechanisms that operate at the molecular level to ensure excellent DNA copying fidelity. Errors that arise during copying can result in gene mutations that cause cancer. Furthermore, when cancerous cells begin to divide uncontrollably, additional copying errors tend to accumulate which themselves then contribute to how the disease progresses. The centrality and importance of this process, and its relevance to the development of cancer, has led a large and diverse group of scientists towards the study of DNA replication in numerous experimental systems. The goal of the conference on Eukaryotic DNA Replication & Genome Maintenance is to provide a forum to bring together a group of scientists working in different areas of this field. The conference will be an open meeting devoted to the most recent advances in the rapidly evolving field of eukaryotic DNA replication and the maintenance of genome integrity. Oral presentations will consist of a combination of invited presentations and presentations selected from submitted abstracts. This practice ensures the participation of a rich combination of junior and senior leaders in the field and the presentation of the most exciting results emerging at the time of the meeting. The oral presentations will be complemented by poster presentations also selected from submitted abstracts.